VAST Center: Viromes Across Space(s) and Time

OVERALL ABSTRACT
The VAST (Viromes Across Spaces and Time) Center proposes to comprehensively identify the human-
associated virome and characterize the viral constituents through a unique set of longitudinal samples
collected from healthy individuals. To advance our understanding of the human virome, we will employ
innovative approaches by accessing unique, well-phenotyped cohorts, exploring diverse lifestyles, engaging
with underrepresented communities, utilizing cutting-edge methods for virome-focused microbiome profiling,
and emphasizing absolute quantification of viruses rather than relying solely on relative abundance
measurements, while also using spatial imaging technology to delineate viral tropism at the subcellular level.
The participating laboratories have collected longitudinal samples from a number unique cohorts including: a)
densely profiled samples from ~171 extensively characterized individuals who have been tracked for up to 13.5
years. Subsets have performed dietary interventions (e.g. fiber supplementation) and lifestyle changes have
been tracked; b) individuals who have been to low earth orbit or Antarctica; c) members of underserved groups
such as Native Americans, Hispanics and African Americans, d) children from underserved groups who have
undergone an exercise intervention; e) individuals who have had their associated airborne samples
(exposome) collected; f) many others. We propose to characterize the virome in depth from these individuals
and correlate virus presence, abundance and changes with features of the cohort: location, ethnicity, diet, and
perturbations including location (space) and lifestyle (diet, exercise).

Public health relevance
OVERALL NARRATIVE The human-associated virome, both mammalian viruses as well as microbial viruses, is expected to be important for human health, yet our understanding of the landscape of these viruses and their dynamics is limited. We propose to characterize the virome in unique cohorts of well-phenotyped individuals who have been tracked for lifestyle, physiology and biochemical (omics) measurements as well as those of diverse populations such as Native Americans to follow virome dynamics across ethnicity, age, clinical markers, physiology, lifestyle (food, activity) and geography, including space and Antarctica.